Mesenchymal Stem Cell Derived Extracellular Vesicles for Traumatic Brain Injury

Project Summary
The goal of the proposed studies is to develop an efficient human mesenchymal stem cell (hMSC)-derived
extracellular vesicle (EV) therapy for improving brain function in both acute and chronic phases after a
traumatic brain injury (TBI). Studies in the previous funding period showed that a single intranasal (IN)
administration of hMSC-EVs 90 minutes after TBI leads to better brain function. Such effects were associated
with the inhibition of the nucleotide-binding domain leucine-rich repeat and pyrin domain-containing receptor
3 (NLRP3) inflammasome-p38 mitogen-activated protein kinase (p38/MAPK) pathway and better
hippocampal neurogenesis. This renewal application proposes studies on the efficacy of hMSC-EVs with
delayed administration in the acute phase or administration in the chronic phase after a TBI. Additional
studies will identify highly enriched miRNAs mediating robust antiinflammatory effects within the hMSC-EVs
cargo and test hMSC-EVs loaded with specific miRNAs for their ability to mediate robust therapeutic effects
in the chronic phase of TBI. Specific Aim 1 studies will investigate whether delayed IN administrations of
hMSC-EVs in the acute phase of TBI would lead to better cognitive and mood function by restraining the
progression of acute neuroinflammation into a chronic state and maintaining better hippocampal
neurogenesis. hMSC-EVs will be administered to young adult mice 4 or 24 hours post-TBI when acute
neuroinflammatory and neurodegenerative processes are active. To understand mechanisms, the studies will
also test hMSC-EVs with a knockdown of select antiinflammatory miRNAs that are highly enriched in their
cargo. Specific Aim 2 studies will examine whether IN administrations of hMSC-EVs in the chronic phase
after TBI would improve cognitive and mood function by modulating chronic neuroinflammation. hMSC-EVs
will be given to young adult mice one-month post-TBI when chronic neuroinflammation and cognitive and
mood impairments are already present. Specific Aim 3 studies will analyze whether loading select miRNAs
into hMSC-EVs cargo enhances their antiinflammatory effects and promotes better cognitive and mood
function when administered in the chronic phase after a TBI. Individual miRNAs with antiinflammatory
properties (miR-30e-3p, miR-let-7c-5p, miR-20b-5p, miR-24-3p) will be loaded into hMSC-EVs and
administered to young adult mice one-month post-TBI. In all Specific Aims, the studies will rigorously
measure hMSC-EVs administration-mediated effects on the transcriptomic signature of activated microglia
and reactive astrocytes via single-cell RNA sequencing, the activation of chronic NLRP3-p38/MAPK and
cyclic GMP-AMP synthase (cGAS)-the stimulator of interferon genes (STING) signaling pathways via
molecular assays, hippocampal neurogenesis, and cognitive and mood function. The proposed translational
research studies are highly relevant to developing an allogeneic, off-the-shelf, hMSC-EV therapy in acute and
chronic phases after a TBI.

Public health relevance
Project Narrative Currently, there are no effective therapies to mitigate the severe brain impairments caused by traumatic brain injury (TBI). The proposed studies will use a mouse model to examine the effectiveness of intranasal administration of extracellular vesicles derived from human mesenchymal stem cells during the acute or chronic phases following a TBI in enhancing brain function. If successful, this intranasal extracellular vesicle therapy could be applied to TBI patients in both acute and chronic phases to improve their brain function.